Screening drug candidates for mitigation against radiation injury in rodents

The contractor shall evaluate the efficacy of drug candidates for mitigation against radiation injury using the AFRRI rodent model system. Drugs will be selected in consultation with NIAID.